Breastmilk antibodies regulate neonatal immunity to the microbiota

PROJECT SUMMARY
To maintain health, the host must avoid generating inflammatory responses to beneficial gut bacteria, while
retaining the ability to respond to pathogens. Maintaining this balance is particularly complicated in early life as
many of the mechanisms that serve to promote tolerance to resident commensal microbes in adults are either
absent or not yet established during this period. We recently identified maternal antibodies as key regulators of
host-microbiota mutualism in neonates. Specifically, we found that in addition to IgA, healthy mothers generate
microbiota-reactive IgG antibodies, which are transmitted via breastmilk and coat bacteria in the neonatal gut. In
comparison with control offspring, neonates that do not receive these maternal isotypes harbor increased
numbers of commensal bacteria in gut draining lymph nodes, mount inappropriate, microbiota-driven CD4 T-
dependent immune responses, and suffer increased morbidity when subjected to a chemical form of colitis.
Building from these exciting findings, this proposal seeks to understand the mechanisms by which maternal
antibodies regulate nascent host-microbiota interactions in neonates. Specifically, we will determine the antigen
specificities and the effector mechanisms (e.g., complement activation or Fc receptor ligation) required for
distinct maternal IgG isotypes to restrain neonatal adaptive immune responses to beneficial gut bacteria.
Additionally, we will define the signaling pathways and cell types required to trigger dysregulated adaptive
immune responses in offspring that do not receive breastmilk antibodies. We will employ innovative approaches
to achieve these goals by leveraging fostering and optimized infant feeding approaches with transgenic mouse
models and multi-parameter flow cytometry. These studies are significant because they address key gaps in our
knowledge regarding how favorable relationships between the host and resident microbiota are established in
early life. Additionally, our work will also advance our understanding of the mechanisms by which breastfeeding
promotes health. We expect that the insight gained from this research will significantly aid in our ability to
manipulate host-microbiota interactions and mucosal immunity during early life, regardless of mode of nutrition.

Public health relevance
PROJECT NARRATIVE Mounting evidence links perturbations in early life host-microbiota interactions with increased susceptibility to immune-mediated diseases later in life, yet we lack a mechanistic understanding of how mutually beneficial relationships between gut bacteria and the neonatal immune system are formed. Building from our discovery that maternal antibodies, delivered via breastfeeding, are key regulators of intestinal homeostasis, this proposal seeks to define the cellular and molecular mechanisms by which maternal antibodies restrain aberrant immune responses to gut bacteria in early life. The resulting data will advance our understanding of the immunological processes that regulate nascent host-microbiota interactions, thereby aiding in our ability to manipulate mucosal immune responses in early life to promote long-term health.